Strategies to target BCR-ABL1 compound mutants in CML and Ph+ ALL

Abstract: Philadelphia chromosome-positive (Ph+) leukemia is caused by BCR-ABL1, a constitutively active
fusion kinase. Tyrosine kinase inhibitors (TKIs) targeting the ATP site of BCR-ABL1 are effective in treating
chronic-phase chronic myeloid leukemia (CP-CML) yet minimally effective at treating blast-phase CML and Ph+
acute lymphoblastic leukemia. In the 20 years since the approval of the first TKI in all of medicine, imatinib, TKIs
have dramatically improved survival of patients with CP-CML, resulting in a projected increase of CML
prevalence from 70,000 Americans in 2010 to 180,000 in 2050. Despite this progress, TKI-resistant CML remains
a challenge, with >1,000 deaths annually in the U.S. At least 50% of TKI treatment failure arises through
mutations in BCR-ABL1. Laboratory studies on the five FDA-approved BCR-ABL1 TKIs have established their
mutational profiles against the >30 mutations observed in patients. In aggregate, these TKIs cover the clinical
spectrum of BCR-ABL1 single point mutants. Ponatinib is the only TKI that is clinically effective against the T315I
gatekeeper mutant. However, BCR-ABL1 compound mutants, defined as 2 mutations in the same BCR-ABL1
allele, that include T315I with any second mutation are resistant to all approved TKIs, including ponatinib, leaving
these patients with no further treatment options. Asciminib is the first inhibitor in clinical development that binds
the BCR-ABL1 myristoyl site, an allosteric site distant from the ATP site, to enforce an autoinhibited, inactive
conformation. We established that asciminib, like ponatinib, is not effective against T315I-inclusive compound
mutants, yet combining ponatinib (but not nilotinib or dasatinib) with asciminib is extremely effective at inhibiting
many T315I-inclusive compound mutant forms of BCR-ABL1. This discovery provides the basis for a novel
therapeutic strategy to address an entirely unmet medical need and is the foundation of this proposal. In Aim 1,
we will use computational, biophysical and crystallographic methods to decipher how ponatinib re-sensitizes
compound mutant BCR-ABL1 to asciminib. We will test the combination in relevant mouse models and in primary
leukemia samples. In Aim 2A, we will develop a therapeutic strategy for clinically resistant BCR-ABL1 compound
mutants that are not inhibited by the combination of ponatinib with asciminib. Instead, we will target these mutants
for proteasomal degradation using an asciminib proteolysis targeting chimera (PROTAC) strategy. Unlike TKIs,
PROTACs are effective even upon transient or weak binding. We will test the hypothesis that ponatinib-induced
stabilization of the myristoyl site is the initiating event that allows subsequent binding of an asciminib-PROTAC
and proteasomal degradation of compound mutant BCR-ABL1. In Aim 2B, we will develop a ponatinib-PROTAC
strategy for compound mutants carrying a myristoyl site resistance mutation. Our work will provide a rationale
for clinical evaluation of ponatinib combined with asciminib as a therapy for currently untreatable BCR-ABL1
compound mutant leukemia. Compound mutations are also a major cause of resistance in acute myeloid
leukemia, melanoma, and lung cancer, and our study will provide a blueprint for treating these malignancies.

Public health relevance
PROJECT NARRATIVE In patients with chronic myeloid leukemia or Philadelphia chromosome-positive acute lymphoblastic leukemia, emergence of BCR-ABL1 compound mutations (two mutations in the same BCR-ABL1 molecule) confers high- level clinical resistance to tyrosine kinase inhibitors (TKIs) and leads to disease relapse. Currently, these patients lack any suitable treatment options, defining an unmet medical need. Our work will mechanistically define three complementary approaches for controlling BCR-ABL1 compound mutation-based TKI resistance and use this knowledge to develop rational strategies to improve patient outcomes.